Investigation of FadA adhesin from Fusobacterium nucleatum

Fusobacterium nucleatum (Fn), a Gram-negative anaerobe, is one of the most prevalent oral species associated with extra-oral infections and inflammation, including Alzheimer’s disease (AD). Serum anti-Fn antibody levels have been found to be significantly higher in AD patients compared to the controls. We have recently discovered that the FadA adhesin of Fn exhibits amyloid-like properties. The amyloid-like FadA mediates binding and invasion of host cells. Accumulation of amyloid proteins is a hallmark of AD. Therefore, we hypothesize that amyloid- like FadA plays a role in AD. Testing this hypothesis is a natural extension of our parent R01, which investigates the role of amyloid-like FadA in Fn virulence, yet not focused on AD. Thus, this supplement application is responsive to the following Notice of Special Interest: Alzheimer’s-focused administrative supplements for NIH grants that are not focused on Alzheimer’s disease (NOT-AG-20-034). We propose to examine the presence of Fn and amyloid-like FadA in AD specimens and compare to matched controls. The ability of amyloid- like FadA in inducing AD-associated pathologies will be examined in both in vitro and in vivo models. Results from this study will shed novel lights on the etiology and mechanism of AD.

Public health relevance
Project Narrative Fusobacterium nucleatum, a common Gram-negative oral anaerobe, has been implicated in Alzheimer’s disease (AD). This study investigates the potential role of its amyloid-like adhesin, FadA, in AD. Results from this investigation will shed novel lights on the etiology and mechanism of AD and will impact patient diagnosis and management in the future. PHS 398/2590 (Rev. 09/04, Reissued 4/2006) Page Continuation Format Page